Post-translational phenotypic profiling through nucleotide barcode sequencing

ABSTRACT
Advances in DNA synthesis and sequencing now enable large-scale experiments that
systematically explore how sequence variation affects molecular and cellular function.
Transcriptional regulation has proven particularly amenable to massively parallel experiments
that have revealed how sequence variation affects the activities of promoters and enhancers as
well as transcription factors. These experiments have relied on high-throughput sequencing of
the mRNAs produced during transcription as a direct read-out of regulatory activity. This
elegant approach cannot be directly extended to study other important modes of biological
regulation, however.
Post-translational protein modiﬁcation underlies nearly all cell signaling pathways. Despite its
importance, we lack general approaches to assess how sequence variation affects post-
translational regulation. We will address this gap with a broadly applicable strategy to link
protein modiﬁcations, such as phosphorylation or regulated degradation, with a deep
sequencing readout. Here we propose to develop this technique and validate it by
demonstrating how protein-level regulation is affected by variation in the target protein, the
modifying enzyme, and the broader genetic context of the cell.

Public health relevance
NARRATIVE Advances in DNA sequencing and synthesis have enabled new ways to understand how differences in the genome affect gene expression. Many important signals between and within cells happen downstream of gene expression, through the post-translational modiﬁcation of proteins. We propose an innovative technique to better understand how genetic variation affects these post-translational signals.